Investigation of state-specific drug binding to cardiac ion channels to reveals mechanisms of arrhythmogenesis

Project Summary/Abstract
Unintended drug block of cardiac ion channels remains a major problem in drug development. The voltage-gated
potassium channel KV11.1 also known as the hERG channel is a major drug anti-target that binds a diverse set
of small molecule drugs. Drug-induced inhibition of the hERG channel reduces the critical repolarizing current IKr
and thereby prolongs the cardiac action potential. Many drugs that bind the hERG channel promote deadly
arrythmias like Torsades de Pointes while some hERG blockers present significantly lower proarrhythmic risk.
Two hypotheses were proposed to elucidate this discrepancy: (1) preferential drug binding to the inactivated
state of the hERG channel confers greater proarrhythmic risk and (2) simultaneous drug binding to other cardiac
ion channels can ameliorate the risk associated with hERG channel block. Here, we present a state-specific
molecular modeling assessment of drug binding to different conformations of the hERG and voltage-gated
sodium hNaV1.5 and calcium hCaV1.2 channels. We have developed structural models of these cardiac ion
channels in open and inactivated conformations and will perform all-atom molecular dynamics simulations to
validate structural stabilities and assess ion conduction. Ligand docking was then performed using Site
Identification by Ligand Competitive Saturation (SILCS), a pre-compute ensemble molecular docking technique.
SILCS allows us to perform a high-throughput assessment of ligand binding affinities using molecular fragment
energy maps derived from molecular dynamics simulations of state-specific ion channel models. Bayesian
machine learning was used to provide improved correlation of SILCS-computed affinities with experimental data.
Using SILCS multi-ligand docking we also estimated interactions of drugs with sex hormones in the hERG
channel pore to assess a potential molecular mechanism for an increased proarrhythmia risk in females. We aim
to use SILCS computed state-specific drug affinity data to inform multi-scale functional kinetic models of cardiac
electrophysiology to estimate emergent drug effects on the cardiac action potential and heart rhythm. These
modeling results will be validated by performing voltage-clamp electrophysiology measurements in vitro and
compared to other published work. Upon completion of this project, the applicant will have refined expertise in
computational modeling of ion channel-drug interactions and will have received training in experimental
electrophysiology for the first time. Throughout the project, the sponsors will implement a training plan to
strengthen the applicant’s knowledge of cardiac physiology and pharmacology while also broadening their
scientific network, and improving the applicant’s scientific communication skills. This plan is tailored such that
the applicant is prepared for a career as an academic scientist, investigating drug interactions with ion channels.

Public health relevance
Project Narrative Previous efforts at developing a computational framework to predict arrhythmia risk based on a drug’s chemical structure have not been able to predict the risk associated with binding the hERG channel and prolonging the cardiac action potential. Atomistic modeling of state-specific drug interactions with the hERG, hNaV1.5 and hCaV1.2 channels is a promising solution. The proposed experiments will allow us to classify the arrhythmogenic risk associated with common drugs, and aid in the screening of new compounds for proarrhythmic risk.